Repurposing FDA-approved drugs to disrupt tau- and amyloid-associated protein-protein interactions in Alzheimer's disease aggregates

Protein aggregation is both diagnostic and causal for neurodegenerative diseases, but also increases with age
in the brain and other organs. Constituent proteins may contribute structurally to aggregates due to their
misfolding and adhesion to other proteins; however, some also play roles in clearance so their sequestration
reduces abundance or availability. We analyzed protein compositions and internal architecture of aggregates
from Alzheimer’s disease (AD) brain tissue. Using a novel cross-linking protocol and neural-network tools to
analyze aggregate “contactomes”, we identified AD-specific protein interactions that are disrupted by RNA-
interference (RNAi) knockdown of either partner, or by drugs that target their interfaces, in human-cell and
C. elegans models of neuropathic aggregation. We identified tau/14-3-3G and hexokinase/14-3-3G among
influential protein interactions, based on neural-network and other machine-learning analyses. These
interfaces were screened for stable binding of FDA-approved drugs, as follows. (i) We first performed a 3-tiered
in-silico screening of molecular-structure libraries, progressively increasing stringency. (ii) Top candidates
from those predictive screens were assessed in biological systems: cultured human-cell and C. elegans models of
AD-like aggregation. The best drug candidates, prioritized by efficacy in suppressing aggregation across these
model systems, will now be pursued in mice. In Aim 1, we will characterize the impact of 4 drugs, two for each
target interface, by analyzing aggregates from human cell lines: Aβ1–42 amyloid from SY5Y-APPSw neuro-
blastoma cells; and tau tangles from SY5Y-tau cells. Each cell line will be exposed to each drug at several
concentrations, or vehicle only (controls), and aggregates will be captured on magnetic beads coated with
antibodies to Aβ or tau. Aggregates insoluble in a strong detergent (sarcosyl) will be cross-linked with
aggregate-permeant “click” reagents, and the linked peptide pairs are identified to define the internal
architecture of these large complexes. By comparing the proteins and their direct contacts between treated
and untreated cells, we will identify proteins, modifications, and interactions most depleted by drug exposure.
In Aim 2, drugs targeting these same interfaces will be assessed for their ability to reduce and/or postpone
cognitive impairment in 3xTg-fAD mice, a model incorporating 3 mutations underlying familial AD pedigrees.
As they age, these mice accrue cerebral amyloid plaque followed by tau tangles. Drugs (at 2 well-tolerated
doses) will commence at either 4 or 12 months of age, with intervals between treatments determined by
bioavailability and clearance times. We will assess cognitive traits just prior to the first doses, and at 4-month
intervals thereafter, based on novel-object recognition (Y-maze format) and 2 IntelliCageTM learning and recall
tasks. The younger mouse groups will be sacrificed at 16 months, while mice commencing treatment at 12
months will be sacrificed at 20 months; at these ages, untreated controls display significant cognitive decline
and cerebral Aβ and tau aggregates. Aggregate interactomes will be analyzed as in Aim 1, from cerebra isolated
postmortem. By comparing controls (vehicle only) to mice receiving drugs, we will learn whether drugs
disrupted their intended targets. We thus can seek multiple correlates of cognitive decline, with adequate
power to detect differences that depend on age, drug, or dose, and any interactions among variables.
These studies, by focusing on AD-specific interactions between aggregate constituents, will open up a new realm
of drug targets not previously explored — protein interfaces that lack any beneficial functions and are absent
from tissues of healthy, young individuals. Drugs targeting these protein interfaces offer a unique potential to
avoid off-target binding and thus to minimize deleterious drug effects. These novel therapeutic agents could
provide effective and well-tolerated interventions to prevent and/or treat AD. Because many aggregate
constituents are shared by diverse neuropathologies (and indeed by many other age-dependent diseases), they
may have broad utility to alleviate a wide range of aggregation-associated pathologies.

Public health relevance
The aged population is at elevated risk of developing dementia, in particular Alzheimer’s Disease (AD). The proposed study will use FDA-approved drugs that target influential protein-protein interaction interfaces found only in AD: tau/14-3-3G and hexokinase/14-3-3G. The top two FDA-approved drug candidates targeting each of the interactions, already shown to markedly reduce aggregation in human-cell and C. elegans models of AD, will be assessed for efficacy in reducing or postponing cognitive decline in a mouse model of aggregation- associated, age-progressive dementia. Such drugs would be of immense benefit to Veterans and the general population, especially those currently diagnosed with mild cognitive impairment or early-stage dementia.